Regulation of cardiac small-conductance calcium-activated potassium channels by PIP2

PROJECT SUMMARY
Cardiac arrhythmia is a condition where the heart’s electrical signals are disrupted, causing the heart to
beat in an irregular and dyssynchronous manner. While some arrhythmias may be benign, others can be life-
threatening, as the ability of the heart to perfuse the vital organs with oxygen and nutrients is severely
compromised. Small conductance calcium-activated potassium channels (SK channels) are activated by the
increase of intracellular calcium concentrations on a beat-to-beat basis. SK channels play critical roles in the
regulation of cardiac excitability, and dysfunction of cardiac SK channels causes cardiac arrhythmias including
atrial fibrillation (AF). Therefore, SK channel may represent a novel therapeutic target for cardiac arrhythmias.
The regulation mechanisms of cardiac SK channels have been extensively studied. Phosphatidylinositol 4,5-
bisphosphate (PIP2) is an essential regulator of many plasma membrane-bound proteins, including cardiac ion
channels. Hence, PIP2 may play critical roles in arrhythmia initiation and maintenance. However, whether and
how cardiac SK channels are regulated by PIP2 are still unknown. We hypothesize that SK channels are
regulated by PIP2 in cardiomyocytes and PIP2 plays a critical role in the trafficking of SK channels. To test the
hypothesis, we will use multidisciplinary approaches including patch-clamp, total internal reflection fluorescence
(TIRF) microscopy, super-resolution immunofluorescence imaging, optogenetics and genetic manipulations.
Three specific aims are: (1) determine the regulation of SK channels by PIP2 using optogenetic techniques; (2)
determine the molecular mechanisms of PIP2 regulation of SK channels; (3) test the physiological impact of PIP2
regulation in cardiomyocytes. These studies will reveal a new regulatory mechanism of cardiac SK channels by
PIP2. The anticipated results will provide novel insights into the functional role of SK channels and PIP2 signaling
in the regulation of cardiac excitability and arrhythmia. At the translational level, cardiac SK channels may
represent a potential therapeutic target for the treatment of cardiac arrhythmia.

Public health relevance
PROJECT NARRATIVE Atrial Fibrillation (AF) is the most common type of cardiac arrhythmia, affecting over 40 million people globally. Small conductance calcium-activated potassium channels (SK channels) retain a unique role in the integration of the intracellular Ca2+ and membrane potentials within the heart. Our approaches integrating patch-clamp, TIRF microscopy, super-resolution immunofluorescence imaging, optogenetics and genetic manipulations may elucidate the mechanism of SK2 channels regulation by PIP2, and present a potential, novel therapeutic target for atrial arrhythmias.